Effect of preimplantation embryo culture on adult glucose homeostasis

DESCRIPTION (provided by applicant): Stress in utero or during the early post natal period plays a cardinal role in shaping future health. An initial stressor, occurring when the embryo is exquisitely sensitive to environmental changes, reprograms the developing gene networks, tissue, and organs so that the resulting individual is predisposed to disease. We hold that suboptimal preimplantation conditions predispose adult individuals to altered glucose homeostasis, leading to an increased incidence of insulin resistance. Our preliminary data show that increased stress during in vitro culture results in proportionate deterioration of gene expression in mouse embryos. Most importantly, we have identified thioredoxin-interacting protein (txnip) as a marker of preimplantation stress. Txnip mRNA and protein levels are upregulated in blastocyst after in vitro culture; suboptimal culture conditions (Whitten's medium- WM) results in a more intense txnip upregulation than culture in optimized medium (KSOM with amino acid, KAA). Txnip expression remains elevated in adult animals and adult mice have impaired glucose homeostasis. Significantly, adults animals cultured in WM have a more severe phenotype than animals cultured in KAA indicating that a memory of the preimplantation stress is maintained in the adult animal. The aberrant txnip gene expression is associated with altered expression of several genes that control DNA methylation, suggesting an epigenetic regulation. Txnip is the principal inhibitor of thioredoxin (txn), a key cellular antioxidant. Txnip levels are regulated by cellular contents of glucose, glutamine, adenosine containing compounds; txnip appears therefore to link the cellular nutritional state with redox state and subsequent metabolic regulation. In addition, txnip is involved in the regulation of peripheral glucose metabolism via downregulation of AKT2/PKB2 pathway and is associated with decreased pancreatic beta cell mass. We propose that (1) txnip is a key element of the embryonic metabolic sensing mechanism and that (2) txnip upregulation in the embryo modifies homeostatic mechanisms so that txnip will remain elevated in adult tissues (3) elevation of txnip in adult tissues results in alteration of glucose homeostasis. To test this hypothesis, we will investigate: (1) how the txnip-txn system responds to progressively worsening environment (2) the mechanisms responsible to maintain elevated txnip expression in adult tissues (3) the phenotype of adult mice generated in vitro. This study is important because will offer insight into basic mechanisms utilized by the preimplantation embryo to respond to different environmental conditions. In addition, data derived from this study can be used to monitor children conceived by assisted reproductive technology (ART). As such, this application is responsive to the Program Announcement (PA-08-104): Adverse outcome of Assisted Reproductive Technologies. Indeed, more than 3 million children have been conceived with the help of ART and multiple studies have reported an increased incidence of maternal and fetal complications in this population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stress in utero or during the early post natal period plays a cardinal role in shaping future health. An initial stressor, occurring when the embryo is exquisitely sensitive to environmental changes, reprograms the developing cells, tissues and organs so that the resulting individual is predisposed to disease. This research is designed to define how progressively worsening stress during early embryo development affect future health. Knowledge gained from this research may lead to novel understanding of the mechanisms used by the embryo to sense and to adapt to different environments. Narrative Stress in utero or during the early post natal period plays a cardinal role in shaping future health. An initial stressor, occurring when the embryo is exquisitely sensitive to environmental changes, reprograms the developing cells, tissues and organs so that the resulting individual is predisposed to disease. This research is designed to define how progressively worsening stress during early embryo development affect future health. Knowledge gained from this research may lead to novel understanding of the mechanisms used by the embryo to sense and to adapt to different environments. __SpecificAimsTextDelimiter__ A. Specific Aims Stress in utero or during the early post natal period plays a cardinal role in shaping future health. An initial stressor, occurring when the embryo is exquisitely sensitive to environmental changes, reprograms the developing gene networks, tissue, and organs so that the resulting individual is predisposed to disease. We hold that suboptimal preimplantation conditions predispose adult individuals to altered glucose homeostasis, leading to an increased incidence of insulin resistance. Our preliminary data show that increased stress during in vitro culture results in proportionate deterioration of gene expression in mouse embryos. Most importantly, we have identified thioredoxin-interacting protein (txnip) as a marker of preimplantation stress. Txnip mRNA and protein levels are upregulated in blastocyst after in vitro culture; suboptimal culture conditions (Whitten's medium- WM) results in a more intense txnip upregulation than culture in optimized medium (KSOM with amino acid, KAA). Txnip expression remains elevated in adult animals and these mice have impaired glucose homeostasis. Significantly, adults developed from blastocysts cultured in WM have a more severe phenotype than those cultured in KAA indicating that a memory of the preimplantation stress is maintained in the adult animal. The aberrant txnip gene expression is associated with altered expression of several genes that control DNA methylation, suggesting an epigenetic regulation. Txnip is the principal inhibitor of thioredoxin (txn), a key cellular antioxidant. Txnip levels are regulated by cellular contents of glucose, glutamine, and adenosine containing compounds; txnip appears therefore to link the cellular nutritional state with redox state and subsequent metabolic regulation [13-15]. In addition, txnip is involved in the regulation of peripheral glucose metabolism via downregulation of AKT2/PKB¿ pathway [13] and is associated with decreased pancreatic beta cell mass [16, 17]. We propose that (1) txnip is a an element of the early embryonic metabolic sensing mechanism and that (2) txnip upregulation in the embryo modifies homeostatic mechanisms so that txnip will remain elevated in adult tissues and (3) elevation of txnip in adult tissues results in alteration of glucose homeostasis. To test this hypothesis, we will investigate: (1) the effect of sub-optimal and optimized culture conditions on the embryonic txnip-txn system (2) the mechanisms responsible to maintain elevated txnip expression in adult tissues (3) the phenotype of adult mice generated in vitro and the downstream pathways activated by txnip upregulation. This will offer insight into basic mechanisms utilized by the preimplantation embryo to respond to different environmental conditions. In addition, information derived from this study could serve as a model to test other environmental insults during the preimplantation time frame and could be applied to monitor children conceived by assisted reproductive technology (ART). As such, this application is responsive to the RFA: Adverse effect of ART. Indeed, more than 3 million children have been conceived with the help of ART and multiple studies have reported an increased incidence of maternal and fetal complications in this population [18]. Having already demonstrated that txnip mRNA and protein levels are elevated following in vitro culture, we propose the following aims: Specific Aim 1: Understand the acute effects of txnip-txn dysregulation in the preimplantation embryo. Sub aim 1a: Investigate whether the PTEN/AKT pathway and glucose transport are altered in in vitro cultured embryos Sub aim 1b: Characterize the impact of txnip up regulation in the embryo, with a specific focus on cell proliferation, apoptosis and oxidative stress. Specific Aim 2: Identify the mechanisms involved in maintaining elevated txnip expression in the preimplantation embryo and in adult individuals. Sub aim 2a. Identify whether epigenetic mechanism(s) are involved in maintaining elevated txnip expression in the preimplantation embryo and in adult individuals. Sub aim 2b. Identify whether increased txnip expression in adult tissue of in vitro generated mice is secondary to increased sensitivity to oxidative stress or to activation of upstream regulatory mechanisms. Specific Aim 3: Investigate the precise relationship between txnip expression in the embryo and adult tissue txnip levels and glucose homeostasis in the adult. Sub aim 3a. Define glucose homeostasis, growth and insulin resistance in adult mice that had altered txnip levels during the preimplantation period. Sub aim 3b. Investigate whether txnip loss protects against glucose defects in adult mice generated by IVF